Novel Over-the-Scope Platform for Control of Variceal Bleeding

Abstract
Upper gastrointestinal (UGI) bleeding from variceal hemorrhage marks a major turning point in the life of a patient
with cirrhosis. Up to 20% of these patients will die from the event. A major shortcoming in the treatment of UGI
variceal hemorrhage stems from the lack of a safe and effective method for controlling refractory bleeding
episodes and maintaining that control until a long-term, definitive therapy can be deployed. Definitive therapy is
generally only available at specialized/tertiary centers. Even at these locations, assembly of the therapeutic team
may take hours before the patient receives the required procedure to stop the bleeding. Massive resuscitation
efforts may be required to maintain the patient’s life prior to definitive therapy. Stop gap measures do exist today,
in the form of blindly placed hemostatic balloons. Many shortcomings have been attributed to the use of these
devices, including esophageal perforation and death. Their ability to stop bleeding varies by location of the
bleeding site, with control rates as low as 0-50% for gastric varices and 50-80% for esophageal varices. Few
clinicians properly deploy these devices, which contributes to the low rates of utilization despite an urgent need.
EndoNavis is a rising medical device company focusing on the focused application of single-use, disposable,
low profile endoscopes for novel clinical applications in the GI space. Our pioneering Over-the-Scope technology
provides new approaches to common clinical disorders. In the setting of variceal hemorrhage, our approach of
endoscopic visualization during placement ensures proper alignment of the balloon with the bleeding site.
Furthermore, direct visualization allows for active monitoring of bleeding cessation. The scope of this project will
focus on mating existing single-use endoscope technology developed by EndoNavis with a novel balloon design.
The project has been tailored to assess essential characteristics of this technology in benchtop anatomic and
bleeding models to verify function and efficacy. Specific Aim 1 will focus on designing a therapeutic
balloon/catheter capable of passage through the UGI anatomy with appropriate optical qualities to ensure
excellent endoscopic visualization. Specific Aim 2 will establish the optimal balloon design to control bleeding
from both esophageal and gastric variceal sources. Specific Aim 3 will assess feasibility of the bleeding control
platform in conducting post-treatment monitoring. The overall deliverable from this project will consist of a
functional bleeding control system ready for next stage verification and validation testing. EndoNavis will seek
approval via the 510(k) pathway. EndoNavis has substantial experience navigating the regulatory hurdles
required for single-use endoscopes. This Phase I grant will support the steps required to establish design freeze
for this technology platform. Additional funds from either a Phase II grant or A round of investor funding will allow
EndoNavis to take the final steps to commercialization. EndoNavis will likely utilize current OEM partners to fully
take this platform to market. An effective, user-friendly and safe alternative to current technology will be a
welcome addition, providing a sure path for entry into the $850B hemostasis segment of the GI market.

Public health relevance
Narrative Gastrointestinal bleeding occurs in over half of the 650,000 US citizens affected by cirrhosis from any etiology. Up to 20% will die from uncontrolled bleeding or its complications. Hospital care costs for bleeding events approach $71,000, accounting for a cost of $2.5 trillion dollars per year. EndoNavis is developing a novel approach to refractory variceal bleeding that will effectively control and monitor bleeding until delivery of definitive therapy.